HISPANIC AND WHITE WOMENS CARDIOVASCULAR HEALTH

DESCRIPTION The proposed study will focus on women, Hispanics, and low SES whites. The goal of the proposed analyses is to elucidate the influence of ethnicity and SES on women s cardiovascular health, using recently completed risk factor and mortality data from the Stanford Five-City Project. Two data sets will be used to evaluate the specific aims: (1) survey risk factor data (e.g., blood pressure, cholesterol, blood lipids, smoking, etc.) on over 4500 girls and women; and (2) surveillance mortality data on over 1800 women.